Transcriptomics of immunity and disease in African Fruit Bats- important zoonotic reservoirs

ABSTRACT In line with the funding goals of the NIH and the objectives of the R21 research program, this project uses the power of transcriptomics to understand bat immune competence in relation to viral infection in a natural, variable environment. This project will be jointly led at Bucknell University by co-PD/PIs Dr. DeeAnn Reeder (internationally recognized expert in bat disease and comparative physiology) and Dr. Ken Field (classically trained immunologist with expertise in applying transcriptomic approaches to bat disease ecology). The goals of this work are to explore how intrinsic (age, sex, reproductive condition, current disease status) and extrinsic (seasonal shifts in weather and food availability) factors underlie immunological variation in African fruit bats, reservoirs for viruses of pandemic potential (including Ebola) that are becoming increasingly associated with people due to habitat modification. While important progress has been made in recent years in understanding bat immunity, much of this has been in cell culture or from limited sampling, largely from SE Asian and Australian bats; this study will fill this taxonomic and geographic gap and transform our understanding of variation in antiviral immunity by examining immune processes in the real world. To perform this work, male and female foraging bats will be collected at field sites in South Sudan during both the rainy and dry season. For Specific Aim 1, spleen tissue samples will be used to determine the differential expression (Illumina HiSeq 4000 platform and Trinity analysis pipeline) of genes involved in immune function, with an emphasis on antiviral immunity. Findings will be confirmed in subsequent qPCR studies and will be used to test the recently proposed hypothesis that bat antiviral gene expression is “always on”, which may be related to reservoir capacity. Relationships found between intrinsic and extrinsic factors and immune gene expression will be used to describe periods of low antiviral immunity, which may increase spillover risk. For Specific Aim 2, gene expression in relation to diseased state will be analyzed for bats with exceptionally high malarial parasite (Hepatocystis) loads or with high viral loads (surveying filoviruses, coronaviruses, paramyxoviruses and orthomyxoviruses), compared to matched controls. For genes with differential expression, qPCR will be used to look for similar changes in other tissues, matched to viral findings (e.g., high viral load from oral swabs will prompt gene expression examination in salivary glands). Relationships between gene expression and disease state will be interpreted in the context of the influence of co-infection (malaria) and of viral infection on antiviral mechanisms. If our proposed specific aims are achieved, we will significantly enhance our understanding of bat immunity and the factors that influence it under natural conditions. This will improve our ability to predict when viral spillovers may be more likely and how changing environmental conditions, including the anthropogenic alteration of natural landscapes, may alter disease processes.

Public health relevance
NARRATIVE The work proposed in this application is essential because it will improve our understanding of bat immunity and the factors that influence it under natural conditions. This enhanced knowledge will improve our ability to predict when viral spillovers may be more likely to occur and how changing environmental conditions; including the anthropogenic alteration of natural landscapes may alter disease processes. In addition to providing compelling evidence of the influence of season, age, sex, reproductive state, and disease burden on immune gene expression, this work will serve as the basis for an ongoing research program that merges the fields of ecological immunology and disease management.